Modeling Hearing and Balance Disorders in Mice: The HEar@JAX Workshop

PROJECT SUMMARY This application seeks partial support for “Modeling Hearing and Balance Disorders in Mice: The HEar@JAX Workshop”, to be held at The Jackson Laboratory (JAX) in Bar Harbor, ME, on September 13-18, 2020. This workshop was held 8 times previously and is one of a kind. It offers lectures and laboratory time in a compact format with a special interest on the auditory and vestibular periphery and mouse genetics. It is an intensive training opportunity for 20 graduate or medical students, postdocs or investigators wishing to gain experience in the fundamental biology and the translational potential of the mouse inner ear. The course is generally aimed at beginners in the field and is structured with classroom lectures in the morning and hands-on laboratory sessions in the afternoon. Seven organizers and nine invited speakers are ideally qualified to give lectures and laboratory training in their own fields. The lectures will address human and mouse genetics-based gene discovery, mouse models of hearing loss and balance disorders, development and regeneration of the inner ear, mechanotransduction, afferent and efferent innervation, brainstem function, noise and age-related hearing loss, ototoxicity and synaptopathy. Modern techniques including single cell approaches, optogenetics and viral and Crispr/Cas9-based gene therapy will be discussed. An otolaryngologist's perspective on patients with hearing loss and a primer on the culture of deafness will also be presented. Laboratory time will include cochlear and vestibular dissection for culture or immunolabeling, transduction channel testing and calcium imaging. Confocal microscopy of fixed or live samples representing normal and mutant tissues will enable participants to observe defects resulting in hearing loss and circling behavior. Other activities will demonstrate inner ear gene transfer, paint-fill, and multiple physiological assessments. All lecture slides and a protocol book of all methods introduced will be made available to participants to maximize the benefits of attending the course. A hallmark of this workshop is the close interaction between participants and faculty at the Highseas Conference Center, which also serves as the residence and dining facility. Sharing meals and other social activities encourages network development and fosters collaboration. To enhance their visibility, participants will have the opportunity to present a poster about their own research. Course organizers: Karen Avraham (Tel-Aviv U), Matt Kelley (NIDCD/NIH), Guy Richardson (U of Sussex), Ronna Hertzano (U of Maryland), Cat Weisz (NIDCD/NIH), Mike Bowl (MRC Harwell), Basile Tarchini (JAX). Invited speakers: Uli Muller (Johns Hopkins U), Ruth Anne Eatock (U of Chicago), Angelica Doetzlhofer (Johns Hopkins U), Kevin Ohlemiller (Washington U), Wade Chien (NIDCD/NIH), Mark Warchol (Washington U), Betsy Driver (NIDCD/NIH), Vidhya Munnamalai (JAX), Leona Gagnon (JAX).

Public health relevance
RELEVANCE TO PUBLIC HEALTH The “Modeling Hearing and Balance Disorders in Mice: The HEar@JAX Workshop” highlights the use of the laboratory mouse as a model to study human auditory and vestibular function. Promoting the responsible use of appropriate animal models is critical to the development of effective new therapeutic approaches for treating hearing loss and balance disorders. Explaining and demonstrating how mice can be used for that goal is also important for the correct public perception of animal research.